Cancer Research Consortium of West Michigan (CRCWM)

PROJECT SUMMARY
The Cancer Research Consortium of West Michigan (CRCWM) is an NCI Community Oncology
Research Program (NCORP) comprised of nine major health systems, a renowned basic
science institute, and a medical school. CRCWM covers the west half of Michigan and cares for
almost 14,000 newly diagnosed cancer patients and their families per year. Formed from two
experienced Community Clinical Oncology Programs (CCOPs) in 2014, CRCWM has a 40+
year history of bringing clinical trials to the community and is a major accruer to NCI studies.
With over 100 oncology physician investigators and a well-established administrative staff,
CRCWM has the ability to enroll patients with cancer diagnoses across the continuum and to
address NCI goals of expanding participation of racial/ethnic minorities and underserved in
clinical trials. This application reiterates our commitment to high-quality research and ongoing
alignment with NCI initiatives.
We are well-positioned to achieve our specific aims for the next NCORP grant cycle which are:
1. To maximize accrual of patients to cancer clinical trials sponsored by the National
Cancer Institute including priority studies for cancer control/prevention,
molecular/precision medicine, and imaging.
2. To be strong contributors to Cancer Care Delivery Research (CCDR).
3. To maximize the sharing of NCI scientific findings into clinical care through education
and engagement of clinical partners and health systems.
4. To address health care disparities experienced by underserved (e.g., rural,
adolescent/young adult, elderly, minority and underinsured) populations within our
communities.
5. To optimize our contribution to the national scientific research agenda by expanding our
leadership and committee participation in the National Clinical Trials Network
(NCTN)/NCORP research bases and the mentoring of young investigators.

Public health relevance
PROJECT NARRATIVE The Cancer Research Consortium of West Michigan (CRCWM) has over 40 years of community-based clinical trial experience and remains dedicated to assuring that every person in West Michigan, regardless of socioeconomic status, race, or geography, has the opportunity to participate in NCTN/NCORP clinical trials for cancer prevention/control, cancer care delivery, and treatment. These trials are the practice-changing research that improve cancer survival, decrease toxicity, and offer better ways to deliver care with decreased costs. Our partnerships with regional health systems allow us to offer over 130 open and accruing cancer research studies, maintain follow-up for 175 additional trials, offer education to targeted populations, and contribute to the knowledge base surrounding the needs of diverse and underserved populations such as children, adolescents and young adults, racial and ethnic minorities, and rural residents.